Bilirubin Catabolism induces Plasminogen-Activator Inhibitor 1 (PAI-1) worsening Metabolic Dysfunction

Summary:
Urobilin is formed in the intestine as a biproduct of conjugated bilirubin catabolism. Currently, the physiological
function of urobilin is unknown. Human association studies have indicated a positive correlation to obesity and
cardiovascular diseases (CVD). Since obesity is a major risk factor for the development of CVD, we hypothesized
that urobilin levels might change with the altered metabolic state and induce adiposity. To determine the role of
urobilin in lean mice, we treated C57/bl6 mice on a normal-chow diet with urobilin for 4 weeks. We found that
urobilin had no effect on body weight but significantly increased adiposity in the inguinal white adipose tissue
(iWAT) depot compared to the vehicle-treated mice. To determine how urobilin changes the transcriptome profile
in the iWAT, we preformed RNA-sequencing which showed that urobilin increases the expression of Serpine1
mRNA. Serpine1 is translated into the protein plasminogen activator inhibitor-1 (PAI-1). PAI-1 is secreted into
circulation, promoting a prothrombotic environment, and is thought to increase the risk of CVD. The goal of this
research proposal is to determine whether urobilin induces CVD via PAI-1 and if this mechanism is a link between
CVD and obesity. We will investigate if lowering plasma urobilin is a possible therapeutic for the treatment and
prevention of CVD. To study this, in Aim 1, we will use PAI-1 knockout (KO) mice and littermate controls treated
with urobilin or vehicle while on a high-fat or calorie-match low-fat diets. We expect the PAI-1KO mice will be
protected from urobilin induced CVD. In Aim 2, we will use diet-induced obese (DIO) mice treated with a liver-
specific GalNac-Ugt1a1-RNAi or GalNac-scramble control to suppress hepatic Ugt1a1, which is responsible for
initiating the conjugation of bilirubin that leads to elevated urobilin production. We show preliminary data that the
RNAi technology suppresses Ugt1a1 94.7% and that this leads to a significant (p<0.01) decrease in plasma
urobilin and an increase in plasma unconjugated bilirubin. We expect that the suppression of Ugt1a1 will protect
the mice from the development of CVD by lowering urobilin levels, increasing unconjugated bilirubin, preventing
adiposity and high PAI-1 plasma levels. This is the first proposed mechanism of urobilin in promoting the
development of CVD, which we will extensively study to better understand how to reverse its deleterious effects.
This fellowship will provided critical training in research techniques, scientific training and professional
development to give me the tools to become a successful independent scientist.

Public health relevance
Project Narrative: The work proposed in this fellowship has the potential to uncover a possible link between obesity and the development of cardiovascular disease. This research could lead to the discovery of a novel biomarker and a possible therapeutic target for the prevention and treatment of cardiovascular disease.